Administrative Core

PROJECT SUMMARY: Administrative Core
The overarching goal of the Administrative Core is to provide the operational support necessary to successfully
achieve the goals we have laid out for each Project, Scientific Core, and our Program as a whole. The
Administrative Core will serve as a central forum for communication, planning, coordination of training, and
common administrative and financial management among the Projects and Cores. We will maximize efficiency,
cost-effectiveness, and productivity by centralizing resources used by each of the Projects and Cores. The
Administrative Core will be led by Dr. Thomas Quertermous and will involve the Project and Core leaders. Internal
and External Advisory Boards will have oversight of the individual Projects and Cores, and will assist with the
overall direction and integration of the PPG as a whole. Day-to-day operations of the Administrative Core will be
overseen by Project Manager Dr. Chong Park. The Administrative Core has the following specific aims: 1)
Establish a collaborative organizational structure to coordinate the administrative and fiscal management of the
entire PPG. 2) Enhance and promote effective communication and cooperation among program leaders and
investigators to integrate the scientific efforts of all Projects and Cores, track timelines and milestones, handle
day-to-day management, monitor project productivity and resources, and perform overall quality control. 3)
Implement a scientific evaluation and oversight program for strategic advice on accomplishing research
objectives and prioritizing future directions. 4) Ensure research compliance with federal policies, university
regulations, and sponsor requirements. 5) Oversee collaborative outreach and broad dissemination of research
results through publications, conference presentations, public lectures, and use of media in collaboration with
Stanford communication offices to promote PPG research, as well as assist with communication and
dissemination of information for stakeholders and the broader research community. 6) Organize the training
component of the PPG, i.e., presentations by trainees at the monthly PPG Research in Progress Meetings, as
well as monthly journal clubs with Project Leaders. 7) Foster diversity in the scientific design of Projects and in
research staff and trainees. The Administrative Core will provide fully integrated administrative services for the
management, communications, coordination, and financial administration of our PPG. In doing so, the
Administrative Core will support the overall PPG in transforming our understanding of genetic risk for vascular
diseases. The Administrative Core will provide centralized resources to each Project and Core, eliminating
redundancy and enabling high-impact research.